Makerere University Data Science Research Training to Strengthen Evidence-Based Health Innovation, Intervention and Policy (MakDARTA)

PROJECT SUMMARY
This is an application for the U2R: Harnessing Data Science for Health Discovery and Innovation in Africa (DS-
I Africa) Research Training Program Fogarty International Research training award. The proposed grant’s goal
is to leverage on the existing partnership between Makerere University and Johns Hopkins University to build a
joint comprehensive Data Science Research Training program to Strengthen Evidence-Based Health
Innovation, Intervention and Policy in Uganda. Cognizant of the fact that, the use of data science analytics in
medicine is already generating new knowledge that is advancing prediction, performance and discovery in
health, the training program aims to; (1) Establish graduate degree training (Master’s and PhD) in data science
for graduating health-professionals at MakCHS, (2) Provide Postdoctoral training that will enable Ugandan
H3Africa alumni to transition into faculty and/or independent data science research leaders and, (3) Train
MakCHS faculty to enhance their capabilities for data science research and mentorship of data science
trainees. The program will comprise of higher degree (Master’s and PhD) and non-degree (Faculty and Post-
doctoral) training with tailored coursework and mentored research training to equip trainees with the requisite
skillset for successful careers in data science. For degree training, our strategy will be to take advantage of the
existing infrastructure and trainings and gradually introduce data science training by selecting trainees from
existing data science relevant Master’s and Doctoral programs; at the same time, we will expand the proposed
Master’s and Doctoral data science curriculum in accordance with Makerere University guidelines, foster
collaborations with other DS-I Africa Training Program PIs with focus on curriculum harmonization and
mapping of the same on core competencies, and seek national, regional and international
accreditation/endorsement. With significant investment in key infrastructure and training at Makerere over the
last 10 years, we believe that sustainable research and training in data science for health is feasible and could
be transformative for Uganda’s health research and care. At the end of the grant period, measurable
parameters of increased research capacity we expect as a result of the training activities shall include (among
others); significant new knowledge generated (as judged from the number of data science for health scientific
publications, policy briefs, etc.), DS-I health innovations generated by trainees, interdisciplinary DS-I research
teams at Makerere.

Public health relevance
PROJECT NARRATIVE Africa is facing a triple burden of disease i.e. a high incidence of fatal infectious diseases, non- communicable diseases, and emerging epidemics (with pandemic potential). Addressing these will require a new thinking and approaches for generating and synthesizing evidence that can inform policy. Research training in LICs provides an avenue to build capacity for locally generated investigations aimed at preventing and controlling these diseases. Leveraging on existing infrastructure at Makerere University College of Sciences and international collaboration with Johns Hopkins University, we propose a plan for a comprehensive multi-disciplinary data science research-training program in Uganda.